Administrative Core

ADMINISTRATIVE CORE SUMMARY
The Administrative Core will be responsible for program coordination, communication with outside entities, and
fiscal management. The core will be led by the PI, Dr. David Erle, who has substantial experience with leading
large NIH-funded multi-investigator programs. The Administrative Core will coordinate activities of the two
projects and the Clinical Subject and Biospecimen Processing and Analysis Core to ensure that critical
information and biospecimens are shared efficiently. The Administrative Core will arrange monthly AADCRC
conferences and meetings with the internal advisory committee and external advisors. We will continue to seek
opportunities to use AADCRC infrastructure and opportunity funds to support a diverse group of early-stage
investigators working to establish careers related to asthma and allergic diseases and to support collaborations
with other AADCRCs. The PI will participate in monthly conference calls with NIAID staff and leaders of other
AADCRCs and will work with other program personnel to ensure we are well-represented at the annual
AADCRC meetings in Bethesda. The PI will work closely with an experienced administrative staff member to
ensure that AADCRC funds are spent wisely and according to all applicable NIH regulations.